Advancing Evidence of the Associations between specific Benign Breast Diagnoses and Future Breast Cancer Risk

PROJECT SUMMARY
The long-term goal of this project is to understand the relationship between specific benign breast disease
(BBD) diagnoses and future breast cancer risk, and to use this knowledge to better identify groups of women at
high risk of breast cancer that may benefit from more intensive primary and/or secondary prevention strategies.
BBD is a common breast biopsy finding and encompasses a diverse spectrum of diagnoses ranging from
normal variations in breast tissue to proliferative changes with or without atypical features. Women with certain
BBD diagnoses are known to have a high risk for development of invasive breast cancer, with risk varying by
degree of histological abnormality with cancerous-like features within the benign lesion. Estimates of risk have
primarily been quantified for BBD diagnoses within known high-risk categories. It is biologically plausible that
other BBD diagnoses may also manifest as distinct risk factors for breast cancer and improve risk prediction.
However, the risks of cancer associated with many specific BBD diagnoses have not been extensively studied,
despite an increasing incidence of BBD detected by screening mammography. Moreover, associations
between BBD diagnoses and cancer risk may be modified by menopausal status or time since diagnosis.
Understanding the magnitude of breast cancer risk associated with specific BBD diagnoses and clustering
diagnoses with similar risk has the potential to inform current breast pathology practice, improve risk prediction
models, and provide evidence for the development of personalized prevention strategies. The objective of this
proposal is to characterize the future risk of invasive breast cancer and ductal carcinoma in situ associated
with specific BBD diagnoses typically combined into two broad categories of non-proliferative lesions and
proliferative lesions without atypia, and to identify clusters of specific diagnoses with similar risk (Aim 1).
Further, we will determine if these associations differ by menopausal status or time since BBD diagnosis (Aim
2). This application leverages the unique research resources of the Breast Cancer Surveillance Consortium,
including a multidisciplinary team of mentors with expertise in risk prediction modeling and risk-based
screening, biostatistics, cancer epidemiology, medicine, and pathology.
These aims will provide a critical understanding of the relationship of BBD diagnoses with future breast cancer
risk. Moreover, our work will inform current breast pathology clinical practice and the development of improved
risk prediction models, identifying lesions with similar risk. The interdisciplinary training environment for this
proposal will provide the applicant the opportunity to gain technical skills, build research competency, undergo
additional educational training, and develop content area expertise to further her career as a future
independent researcher.

Public health relevance
PROJECT NARRATIVE Benign breast diseases are common findings on breast biopsy, and certain benign diagnoses are known to be associated with a high risk for development of breast cancer; however, the etiology and risk of cancer associated with other specific benign breast diseases have not been extensively studied or quantified. This study leverages data on over 2.1 million women from 7 diverse Breast Cancer Surveillance Consortium breast imaging registries across the U.S. with up to 25 years of follow-up to identify specific benign breast disease diagnoses and accurately quantify their associations with future breast cancer risk. Our results will provide a better understanding of the relationship between benign breast disease and breast cancer risk among premenopausal and postmenopausal women and by time since diagnosis and may identify subgroups of women most likely to benefit from targeted screening and other prevention efforts.